FRONTIERS IN SCIENCE CONFERENCE

Abstract/Summary Frontiers in Science Conference synergizes with the NICHD-funded Pediatric Scientist Development Program focusing on pediatric residents-in-training and encouraging careers in academic pediatrics as future physician-scientists.

Public health relevance
Narrative/Relevance Statement This Frontiers in Science Conference supports residents-in-training to become future pediatric physician-scientists.